Core E: Research Support - Chemical Core

Project Summary: Analytical and Environmental Chemistry Core (AECC)
As part of this renewal application we are incorporating a new Research Support Core (RSC-II) which will serve
as an Analytical and Environmental Chemistry Core (AECC). The AECC will directly support the BCM-Rice
Superfund Research Program (SRP) and its four projects, ensuring integration with the other cores within the
Center. The AECC will provide a wide range of accurate and precise measurements of select organic and heavy
metal pollutants, providing reliable data for research and quality control purposes, and implementing robust
analytical methods. The AECC will focus on the chemical analysis of polycyclic aromatic hydrocarbons (PAHs)
in placenta tissue and soil/sediment. Specifically, the AECC will focus on the analysis of the 16 PAHs, designated
as High Priority Pollutants by the U.S. EPA, working with Projects 2 & 3 to measure these levels in tissues.
Additionally, the AECC will assess the presents of PAH metabolites and or degradation products in key samples
from soil in collaboration with Projects 1 and 4. The AECC will also quantify the concentration of select organic
pollutants (e.g., polychlorinated biphenyls; PCBs) and heavy metals (e.g., arsenic, lead, and cadmium). The
AECC will support the study of the impact of PAHs as risk factors for preterm births in women living near
Superfund sites, identifying and quantifying pollutants, and developing strategies for remediation and pollution
prevention. The AECC will be housed at Baylor University (BU) under the leadership of co-Director Dr. Sascha
Usenko, Full Professor at Baylor University, and co-Director Dr. George Cobb, Department Chair and Full
Professor at Baylor University. The AECC leadership has decades of experience in high-throughput chemical
and elemental analysis using various mass spectrometry techniques and instrumentation.

Public health relevance
Project Narrative: RSC-II The primary objective of the Analytical and Environmental Chemistry Core (AECC) / Research Support Core II (RSC-II) is to accurately measurement hazardous organic compounds and metal concentrations in human blood and tissue, animal tissues, and soil/sediments. Specifically, the core will measure polycyclic aromatic hydrocarbons (and their metabolic or degradation products) and other environmental contaminants originating from superfund sites located in Harris County. These measurements directly support the BCM-Rice SRP and its four projects, which aim to explore the potential heightened risks of preterm birth and neonatal lung injuries.